DIETARY MODIFICATION OF THE COURSE OF PROGRESSIVE RENAL DISEASE

The purpose of this study is to examine the efficacy of dietary modification in the treatment of progressive renal disease. This study compares the effect of a low protein and phosphorus diet with moderate protein and phosphorus restriction on the course of progressive renal disease.